Inhibitors of b-arrestin

Recent discoveries in GPCR signaling have elucidated multiple critical roles of beta-arrestins which are scaffolding proteins that regulate GPCR internalization and signaling. Beta-arrestins are promising to clinical targets, because mice with a knockout of a single beta-arrestin have no overt phenotype, while dual knockout of beta-arrestin1 and beta-arrestin2 is lethal. Also, bladder cancer cells express elevated levels of beta-arrestin2 and one of its activators, the thromboxane-beta GPCR. This increase correlates with a poor clinical prognosis and suggests beta-arrestin2 as a bladder cancer target. Although GPCRs are a major clinical target, to date there are no small molecule regulators for beta-arrestins. Using high performance docking on the NICS Kraken supercomputer, we have conducted virtual screening of a 1.4 million compound library and identified ~250 potential beta-arrestin2 inhibitors. We then created and validated a high throughput and high-content screen targeting GPCR/ B-arrestin2 interactions and tested 61 predicted inhibitory compounds, 15 of which decreased receptor internalization by >40%, validating our discovery strategy. We will complete the screening of all the predicted inhibitors and carry out lead optimization to increase their potency and selectivity for beta-arrestin2. The resulting first selective inhibitors of betaarrestin2 will be used to determine their effect and selectivity on downstream GPCR signaling events in model cell systems. We will also test our beta-arrestin2 inhibitor for anticancer activity using cell based and animal models of bladder cancer. The success of this study will warrant the development of beta-arrestin2 inhibitors as therapeutic agents for bladder cancer and other diseases associated with aberrant betaarrestin- mediated signal transduction.

Public health relevance
Beta-arrestin-2 is a protein implicated in several diseases, including bladder cancer, but no inhibitors of beta arrestin- 2 currently exist. The proposed project will create